Allergen-induced extracellular DNA in type 2 immunity

PROJECT SUMMARY/ABSTRACT
The long-term objective of this project is to investigate the fundamental immunological mechanisms
involved in the development of asthma and allergic airway diseases. Various atmospheric factors contribute to
the pathogenesis of these diseases, including viral infection, allergen exposure, and air pollution. It is
becoming increasingly clear that the airway epithelium plays a key role in orchestrating immune responses in
the airways. Nonetheless, the mechanisms involved in the initiation and development of immune responses to
environmental factors are not fully understood.
Sensing of self-DNA by immune cells has been implicated in sterile inflammation in various organs and the
pathophysiology of diseases. We recently found that human airway epithelial cells rapidly release fragments of
nuclear DNA into the extracellular milieu following allergen exposure in vitro. Caspase-3 was rapidly activated
in airway epithelial cells upon allergen exposure without apparent signs of cellular apoptosis or necrosis. Self-
DNA was also released into the airway lumen in naïve mice exposed to allergens in vivo, and blocking
extracellular DNA (eDNA) suppressed type 2 immune responses to the allergens. Therefore, we hypothesize
that allergen-induced rapid extracellular release of self-DNA by airway epithelial cells promotes type 2 immune
responses to airborne allergens.
The experiments described in this proposal will investigate this hypothesis by focusing on two fundamental
questions. In Aim 1, we will determine how DNA is rapidly released by airway epithelial cells in response to
allergen exposure in vitro. We will examine the mechanisms of non-canonical activation of caspase-3 and
calpains, which initiate and terminate active DNA release, respectively. In Aim 2, we will determine how
epithelium-derived eDNA promotes type 2 immunity and allergic airway inflammation in vivo. We will
investigate the role of the pattern recognition receptor for advanced glycation endproducts (RAGE) in sensing
eDNA and leading exaggerated effector functions of group 2 innate lymphoid cells and CD4+ T cells.
We will employ a combination of complementary expertise in cellular and molecular biology of airway
epithelial cells and immunology and disease models of type 2 immunity in the laboratories of Dr. O’Grady and
Dr. Kita, respectively. Novel and robust in vitro and in vivo models have been developed for this project. These
studies will provide a better understanding of how airway epithelium responds to environmental allergens and
will define the key molecules responsible for type 2 immune responses in the airways. Ultimately, these studies
will characterize the critical mechanism(s) involved in allergen-induced immune responses, allowing for the
identification of novel therapeutic target(s) for treating and ideally preventing immune-mediated airway
diseases, such as asthma, chronic rhinosinusitis, and other allergic disorders.

Public health relevance
PROJECT NARRATIVE The long-term objective of this project is to investigate the fundamental mechanisms underlying the etiology of allergic airway diseases. Specifically, we will investigate how the exposure of airway epithelium to environmental allergens initiates the immune responses that culminate in the disease process. Successful completion of this project will provide new prevention and treatment strategies for these diseases.